People living with HIV (PLWH), Oral and Oropharyngeal Cancer, and Health Equity: A Qualitative Study

Project Summary
People living with HIV (PLWH) have an estimated 1.6-6.0 times increased risk of developing
oropharyngeal squamous cell carcinomas (OPSCC) compared with individuals in the general population.
Approximately 70% of OPSCC are caused by HPV, and PLWH also have an increased prevalence of oral HPV
infection compared to the general population. While a smaller proportion of oral squamous cell carcinomas
(OSCC) are attributed to HPV, PLWH also have an increased risk of developing HPV-associated OSCC.
Disparities exist among racial/ethnic groups for OSCC/OPSCC outcomes and Black individuals with OPSCC
and OSCC have worse survival, a later stage of diagnosis, and less frequent cancer directed treatment than
other racial/ethnic groups. HPV-associated OSCC/OPSCC are potentially preventable through HPV vaccination.
Although oral cancer screening is not recommended for the general population, early detection is associated
with improved survival and screening may be important in racial/ethnic minority groups.
Oral health care providers may be the first point of contact for OSCC/OPSCC prevention strategies.
PLWH have dental insurance provided through the Ryan White Care Act. Even so, more than half of PLWH have
unmet oral care needs and 58-64% do not receive regular dental care. PLWH also face stigma and/or
discrimination from living with HIV, including in the dental office, and may also have other intersectionality with
sexual and gender minority (SGM) groups, for which there is additional stigma. Understanding the experiences
of PLWH and the barriers/facilitators of oral health, through a lens of health equity, is needed before interventions
can be designed to engage PLWH with intersecting identities in OSCC/OPSCC prevention activities.
As a first step, we propose to conduct a qualitative study among PLWH of diverse racial/ethnic and SGM
identities to: (1) explore individual, interpersonal, and structural oral health equity factors that serve as barriers
or facilitators of accessing oral health care, (2) to explore knowledge and perceptions of HPV vaccination and
OSCC/OPSCC, and (3) to collect recommendations on how to increase access to oral health care and engage
PLWH in OSCC/OPSCC prevention. We will conduct approximately 12-18 focus groups with 5-8 individuals
grouped by common identity group. These groupings may be by race/ethnicity, gender identity, sexual
preference, or a combination of identities. The results of this study will be used to: 1) inform the design of a
multilevel, culturally appropriate intervention to increase engagement with oral health care and HPV-
associated OSCC/OPSCC prevention activities. The PI will design a randomized controlled trial to evaluate
the intervention’s impact on HPV vaccination, OSCC/OPSCC knowledge, and retention in oral health care;
and 2) assess the risks and benefits of OSCC and novel OPSCC screening among PLWH from diverse
racial/ethnic identity groups. Screening PLWH at high risk for HPV-associated OSCC/OPSCC and from of
groups with poor 5-year survival from OSCC/OPSCC may prove beneficial in reducing cancer-related mortality.

Public health relevance
Project Narrative People living with HIV (PLWH) are at increased risk of human papillomavirus (HPV)-associated oropharyngeal and oral cancers and disparities exist among racial/ethnic groups and sexual or gender minority groups (SGM). Through focus group discussions, this study will explore experiences accessing oral health care in PLWH that identify as members of different racial/ethnic and/or different SGM groups. These findings will inform the design of a multilevel, culturally appropriate intervention to increase engagement with oral health care and in HPV-associated OSCC/OPSCC prevention and screening activities.